Adapting 5MCAR technology for the treatment of peripheral T cell lymphoma

PROJECT SUMMARY
CD4+ T cells respond to peptide antigens presented by MHCII molecules (pMHCII) using a 5-module molecular
machines composed of a receptor module [the T cell receptor (TCR)], three signaling modules (CD3, CD3,
CD3), and a coreceptor module (CD4). Drawing upon this blueprint, we designed a biomimetic 5-module
chimeric antigen receptor (5MCAR) system composed of a chimeric receptor module, built with pMHCII and
TCR components (CRMpMHCII), that assembles with the CD3 signaling modules and works with a surrogate
coreceptor (ScoR) to generate signals in response to specific TCRs. As we recently reported (Kobayashi, et
al., PNAS 2020), 5MCAR-CTLs can specifically target and kill pathogenic CD4+ T cells that express TCRs that
bind the CRMpMHCII. Given that peripheral T cell lymphomas (PTCLs) represent a unique type of pathogenic T
cell for which treatment options are limited, and patient prognosis is poor, we are motivated to ask if our 5MCAR
technology can be developed into a patient-specific PTCL therapy. As PTCLs are often derived from
transformed CD4+ T cells and express a clonotypic TCR that represents a tumor-specific antigen, we
consider them to be ideal targets for 5MCAR-CTLs. Accordingly, the goal of the current study is to establish a
workflow whereby our 5MCAR technology is used to screen libraries of CRMpMHCII for mimotope CRMpMHCII that
signal in response to the clonotypic TCR of a PTCL, and then use the identified mimotope CRMpMHCII to
generate 5MCAR-CTLs for targeting the PTCL via its clonotypic TCR. When completed, the established
workflow will provide a blueprint for adapting our 5MCAR technology into a personalized therapy to treat
patients with PTCLs.

Public health relevance
PROJECT NARRATIVE Recent advances in treatment options have dramatically improved the clinical outcomes for B cell non- Hodgkin’s lymphoma (NHL) patients, but the treatment options for patients with T cell NHL are more limited and their prognosis remains poor. We have engineered a biomimetic 5-module chimeric antigen receptor (5MCARs) to target pathogenic T cells and demonstrated that 5MCAR-CTLs can efficiently eliminate pathogenic T cells in vivo. Here we will develop a workflow to adapt our 5MCAR technology for the personalized treatment of peripheral T cell lymphomas (PTCLs).